Substance Use among Biracial Adolescents and Emerging Adults: The Double Jeopardy Hypothesis

PROJECT SUMMARY
The biracial population is the second-fastest growing demographic group in the US. Biracial adolescents
also have higher risks of substance use as well as violent behavior, school problems, and poor physical and
mental health than many of their monoracial peers. However, little is known about substance use prevention
and interventions in this population. Historically, biracial youth have been either ignored in research or their
many subgroups have been combined into a single “multiracial” category, potentially obscuring clinically
relevant patterns. Moreover, no accepted model explains the factors that increase or decrease the risk of
substance use among biracial youth. Discoveries made during the course of the proposed research will help
accelerate the refinement of existing prevention and intervention programs for biracial adolescents and
emerging adults, and will speed translation of its findings into public health practice.
We propose to study the 4 subgroups of biracial youth that our prior research has shown to have the
highest risk of substance use, namely biracial White-American Indian, White-Asian, White-Black, and White-
Hispanic youth. In doing so, we will also test a newly developed model, the Double Jeopardy Hypothesis, that
we propose to explain biracial substance use patterns. According to this model, biracial individuals experience
not only the common risk factors for substance use, which are also experienced by monoracial youth but also a
second set of risks unique to being biracial in America.
This study takes advantage of existing data from two large, longitudinal and nationally representative
databases that include adequate numbers of biracial persons to allow the sample to be divisible into subgroups,
as well as multiple measures of social determinants of health (e.g., perceived discrimination, racial
socialization), substance use, and other behavioral and physical outcomes. The first, Monitoring the Future,
followed students from middle-/high-school through age 55 years. The second, the National Longitudinal
Study of Adolescent and Adult Health, followed students from age 11 to 42 years.
After integrating the two datasets using integrative data analysis to study adolescents and emerging
adults ages 13-25 years old (Aim 1), we will determine the onset, prevalence, and developmental trajectories of
substance use (i.e., cigarette, alcohol, marijuana, and polydrug use) from adolescence to emerging adulthood
(ages 13-25) (Aim 2). Last, we will explore the relationships of common and unique risk and protective factors
(in the individual, family, peer, school, and community domains) for substance use among biracial adolescents
and emerging adults, examining evidence for the proposed Double Jeopardy Hypothesis (Aim 3).
Findings will inform more effective and inclusive prevention approaches for an understudied but rapidly
growing sector. If accurate, the Double Jeopardy Hypothesis will provide insight into the lived experience of
biracial adolescents and emerging adults, forming a framework for future research on a range of outcomes.

Public health relevance
PROJECT NARRATIVE Sociodemographic changes and revised US Census questions have led to new recognition of the growth in the proportion of people self-identifying as biracial. However, despite calls from NIDA for etiological research to inform primary prevention of adolescent substance use, little is known about substance use among biracial youth. The proposed research aims to provide information critical to both the speedy refinement of existing programs and the creation of targeted programs for biracial adolescents and emerging adults. 1